Helium Recovery for the ICR and NMR/MRI Facilities at the National High Magnetic Field Laboratory in Tallahassee, FL

Project Summary Nuclear magnetic resonance (NMR) spectroscopy and Ion Cyclotron Resonance (ICR) are exceptional experimental tools for understanding the intricacies of biology and chemistry from macromolecular complexes to complex mixtures, from atomic resolution structure to a characterization of dynamics and an understanding of functional mechanism and rates. ICR has an increasingly broad role to play in the characterization of exceptionally complex mixtures from bio fluids to oil, from large proteins to their complexes. These two complementary technologies at the NHMFL have drawn large groups of users from NIGMS funded research groups as well as research groups both from the national research community but also from international research groups. While the Resonance Wing of the NHMFL that houses the ICR and NMR/MRI User programs has been equipped to recycle much of the boil off from its superconducting magnets, the vast majority of this boil off He gas is generated from the pumped magnets leading to significant contamination of the recovered gas. This has forced the Helium liquefier to operate in “impure” mode, which is an inefficient mode of operation that has saturated the capacity of the liquefier. With the purchase of a purifier through funding of this proposal the liquefier can then operate in “pure” mode at a much faster rate. With this capability the collection of not only the boil off, but also the gas from the LHe filling operations of the superconducting magnets can also be collected allowing the laboratory to approach its goal of recycling 95% of its Helium. This corresponds to an additional 30,000 liter of LHe that would be recycled.

Public health relevance
Project Narrative Liquid helium (LHe) is a valuable resource for multiple communities in the United States affecting the medical community with its 11,000 MRI instruments and, the biomedical science, materials science and chemistry research communities with a vast number of NMR spectrometers all in superconducting magnets which are dependent on LHe. Some day maybe high temperature superconducting materials will permit the construction of magnets using liquid nitrogen but, for the foreseeable future, the solution must be to preserve our LHe resources and hence the focus of this proposal aiming to enhance the recycling of LHe gas from 50% to 95% in these internationally renowned ICR and NMR/MRI user facilities.